Passive cognitive assessment across the menopausal transition

PROJECT SUMMARY
Menopause is a traditionally underappreciated and undertreated condition that affects approximately 1 billion
women worldwide. Half of those women also have significant symptoms associated with the menopausal
transition, including sleep disturbances, vasomotor symptoms, and brain fog or cognitive dysfunction. One of
the reasons for the treatment gap in menopause care relates to difficulties in obtaining reliable measures of
cognitive dysfunction with high temporal resolution. The goal of the proposed project is to further develop and
test a novel, passive, unobtrusive tool for assessing cognitive function through smartphone interactions, called
Skye, for use in peri- and post-menopausal women. Phase I will support the cross-platform development of
Skye (Aim 1) and will test the feasibility and usability of Skye, utilizing an iterative design process with two
focus groups of peri- and post-menopausal women from diverse socioeconomic and racial/ethnic backgrounds
(Aim 2). In Phase II, we will leverage existing studies funded by the National Institute on Aging to validate the
cognitive score derived from Skye with gold-standard neuropsychological assessments and neuroimaging
measures. We will further test the hypothesis that Skye is sensitive enough to detect cognitive changes
secondary to sleep disturbances and vasomotor symptoms in peri- and post-menopausal women (Aim 3). The
successful achievement of the Aims will provide vital evidence for the utility of Skye in addressing the unmet
needs of a growing market estimated to cost the United States $26.6 billion annually.

Public health relevance
PROJECT NARRATIVE Menopause is often overlooked and under-treated, affecting around 1 billion women globally, many of whom experience significant cognitive and physical symptoms. This project aims to develop and test a smartphone tool designed to unobtrusively assess cognitive function in peri- and post-menopausal women, ultimately providing a valuable solution to an under-addressed healthcare need.